RHU IL-10 (SCH52000) IN PATIENTS WITH MILD/MODERATE CROHN'S DISEASE

The purpose of the study is to study the efficacy, safety and tolerance of multiple doses of subcutaneous SCH 52000 in patient with mild to moderate Crohn's disease.